Defining a novel mechanism of adhesion present in multiple infective endocarditis causing species

The pathogenic mechanisms leading to subacute infective endocarditis (IE) are poorly understood, limiting the
development of preventative and therapeutic strategies. However, bacterial binding to platelets is accepted as
a key step in infection. Streptococcus oralis and Streptococcus mitis are viridans group streptococci that are
common, but rarely studied, causes of IE. Terminal sialic acid is the major platelet receptor for many viridans
group streptococci. Until recently, all known streptococcal-sialic acid interactions were mediated by members
of the serine-rich repeat protein (SRRP) family of adhesins. That paradigm was shifted by identification of a
novel sialic acid-binding protein, AsaA, in S. oralis. Binding of both SRRPs and AsaA is mediated by sialic acid
immunoglobulin-like lectin (Siglec)-like domains. While most SRRPs contain one, AsaA contains two putative
Siglec-like domains. The first Siglec-like domain contains a sialic acid-binding motif; however, the second
Siglec-like domain is the first described to completely lack this motif. A polypeptide consisting of the two Siglec-
like and Unique domains directly binds sialic acid on platelets. However, the role of each Siglec-like domain
and the specific proteins bound are unknown. AsaA orthologs were identified in four IE-causing species with no
previously described mechanisms of adhesion. Together, these data led to the hypothesis that AsaA and
orthologs are members of a novel family of sialic acid-binding adhesins, that contribute to IE by binding host
components via two Siglec-like domains. Three aims will test this hypothesis. Aim 1: Determine the role of the
two AsaA Siglec-like domains in binding IE-relevant host components. Defined mutants and recombinantly
expressed proteins will be used to resolve the contribution of the two different Siglec-like domains to platelet
binding and to identify the specific proteins bound by each domain. Furthermore, the range of IE-relevant host
components bound by AsaA and the role of the two Siglec-like domains in these interactions will be
established. Aim 2: Determine whether AsaA is a member of a novel family of sialic acid-binding adhesins. The
role of AsaA orthologs in platelet binding will be investigated, with a focus on S. mitis. Aim 3: Determine the
contribution of AsaA, and specifically sialic acid binding, to IE using a 3D human microvessel model. A cutting-
edge physiologically relevant and tractable 3D microvessel model will be used to assess the role of sialic acid,
AsaA, and the Siglec-like domains in establishment of a vegetation. Furthermore, experiments will ascertain
whether this adhesion mechanism could be a therapeutic target. This application is significant as it focuses on
bacteria with no previously described mechanisms of binding platelets, a critical step in development of
subacute IE. Innovative aspects of this proposal include defining the function of a novel Siglec-like domain and
utilizing a cutting-edge 3D microvessel model. This study will also likely identify a novel family of sialic acid-
binding adhesins produced by multiple IE-causing species, which may bind the same receptor as SRRPs
making these interactions an attractive target for intervention.

Public health relevance
Project Narrative The proposed research is relevant to public health because defining pathogenic mechanisms of bacteria that cause infective endocarditis is ultimately expected to lead to the development of more effective prognostic, diagnostic, preventative or therapeutic measures. Hence, the proposed research is relevant to the part of the NIH’s mission which pertains to gaining fundamental knowledge that will enhance health and reduce illness.